CLINICAL AND MOLECULAR STUDIES OF GAUCHER DISEASE

The objectives of the research are to delineate and correlate the clinical, biochemical and molecular heterogeneity within and among the variants of Gaucher disease (acid beta-glucosidase deficiency), the most prevalent lysosomal storage disease. the availability of a large cell bank from Gaucher disease patients and a large number of new patients provides an opportunity for the evaluation of molecular correlations for the development of pre- and postnatal prognostic tests as a basis for therapeutic interventions.